Interneurons differentially regulate discrete pathways from ventral hippocampus

Project Summary/Abstract
The current application is for an Administrative Supplement for Continuity of Biomedical and Behavioral
Research Among First-Time Recipients of NIH Research Project Grant Awards. Hippocampal microcircuits are
comprised of excitatory pyramidal cells, which integrate information and innervate downstream brain regions,
and inhibitory interneurons, which function locally to regulate pyramidal cell activity and synchronicity. In the
ventral hippocampus (vHipp), microcircuit dysfunction has been associated with a variety of neurological
disorders, including neurodegenerative diseases, neurodevelopmental disorders, and psychiatric illnesses.
Previous work has demonstrated that vHipp pyramidal cells differentially regulate schizophrenia-like behaviors
depending on their downstream target. Similarly, unique classes of inhibitory interneurons (namely parvalbumin
(PV)-positive and somatostatin (SST)-positive) also differently regulate schizophrenia-like behaviors. Therefore,
the overarching hypothesis of the current proposal is that PV- and SST-positive interneurons differentially
regulate the function of vHipp pyramidal cells depending on their projection target. During the K99 phase of the
award, enhanced GFP recombination across synaptic partners (eGRASP) and electron microscopy were used
to demonstrate that PV- and SST-positive interneurons differentially innervate vHipp pyramidal cells depending
on their target (i.e. the NAc or mPFC). Specifically, PV-positive interneurons form a similar number of synapses
on pyramidal cells that project to both the NAc and mPFC. SST-positive cells, however, form significantly fewer
synapses on pyramidal cells that project to the mPFC. Further, fiber photometry, in vivo electrophysiology, and
optogenetics were used to test the functional regulation of NAc vs mPFC projecting pyramidal cells by PV- and
SST-positive interneurons in the vHipp. We found that PV-positive interneurons regulate the function of
pyramidal cells that project to either the NAc or the mPFC while SST-positive interneurons only regulate the
function of NAc-projecting pyramidal cells. These findings are in line with previously collected behavioral data
demonstrating that SST-positive interneuron transplants have little impact on behaviors associated with the
vHipp-mPFC pathway. During the R00 phase of the award, we have begun to test the hypothesis that microcircuit
anatomy and function are altered by chronic stress, a predisposing factor for many neurological disorders, using
eGRASP and fiber photometry. In line with the goals of the BRAIN Initiative, the results will provide insight into
basic principles of neural circuit function and may lead to new strategies for the treatment and prevention of
devastating neurological disorders. The Administrative Supplement will ensure that progress is made as the PI
undergoes treatment for breast cancer.

Public health relevance
Project Narrative The ventral hippocampus is a brain region that has been implicated in a variety of neurological disorders, including psychiatric diseases, neurodevelopmental disorders, and neurodegenerative diseases. The current experiments will provide a better understanding of the structure and function of neural circuits in the ventral hippocampus both in healthy animals and after chronic stress, a risk factor for the diseases listed above. A comprehensive understanding neural circuit anatomy and function may provide new targets for prevention and treatment strategies to alleviate the burden of neurological disorders.